Shared Language Erosion Among Chinese Immigrant Families

Project Summary/Abstract
Accusations regarding the origins of COVID-19 and ongoing anti-China rhetoric have provoked increases in
mental health problems (MHPs) such as anxiety, depression, and suicidal thoughts and behaviors among
Chinese American immigrant (CAI) families. Yet, little is known about how CAI families cope with
discrimination. Additionally, there is a well-documented increase in the prevalence of MHPs from the 1st to the
2nd and 3rd generations of CAIs. However, little is known about what might be driving this increase.
A growing literature shows that upon entering school, immigrant children in general, and Chinese-heritage
children in particular, quickly acquire proficiency in English while exhibiting significant declines in their heritage
language (HL). Over the same time period, their parents show only modest gains in their English proficiency.
The combination of child HL loss and low parental EL acquisition creates a situation in which immigrant
children and their parents increasingly do not speak the same language, which we call shared language
erosion (SLE). This dynamic creates a growing barrier for Chinese parents and their children to communicate
effectively. When communication falters, misunderstandings, frustrations, conflict, and feelings of rejection
grow, causing disharmony in the family. Parental competencies that normally would buffer against
environmental risks become increasingly ineffective leaving youth vulnerable to the negative impact of
discrimination and stress. This may help explain why 2nd and 3rd generation Chinese immigrants are 2~3 times
more likely to develop a mental illness and/or attempt suicide relative to their 1st generation counterparts.
Because language is the mechanism through which meaning, identity, and relationships evolve and are
strengthened, SLE may also impede the development of other protective factors against MHPs such as ethnic
identity, engagement with extended kin, and a sense of belonging to an ethnic community. However, these
mediated paths from SLE to youth MHPs have not been tested. To assess these linkages the current study
aims to: 1) Examine the extent to which the association between SLE and Chinese American immigrant
youth's MHPs is mediated by parental efficacy (e.g., monitoring, low conflict, closeness), and whether
this path is moderated by youth gender; 2) Examine whether the path from perceived discrimination to
MHPs through youth stress is moderated by SLE among CAI youth. We hypothesize that SLE will be
positively associated with MHPs, that this association will be mediated by parental efficacy, and will be
stronger for females. We also hypothesize that high SLE will exacerbate the negative effects of discrimination
on youth MHPs by increasing the indirect effect through youth stress. To accomplish these aims we will sample
167 Chinese immigrant parents (1st generation) whose preferred language is Mandarin and their 1st or 2nd
generation youth children (ages 12-17; N=167 parent-child dyads) who have resided in the US for 6 or more
years.

Public health relevance
Project Narrative This study has important public health implications in that it will provide preliminary evidence for shared language erosion as a novel intervention target to reduce mental health problems (MHPs) among a rapidly increasing at risk population of Chinese Immigrant Youth.